Patient-Oriented Research Mentorship and Training in Upper Airway Allergic and Inflammatory Diseases

Project Summary/Abstract
The cytokines IL-4, IL-5, and IL-13 are thought to be key effectors of airway inflammation, but remarkably
little is known about either their global function within the respiratory tract or the potential consequences of
their complete inhibition by newly available biologic drugs. The overall goal of the proposed research is to
define the underlying human biology of IL-4Rα and IL-5R signaling in airway inflammation, both their role in
driving type 2 inflammation and their role in counterregulating other systemic immune pathways. We will
determine the cell-specific impacts of these cytokines within the respiratory tract and confirm the influence
of IL-4Rα and IL-5R on the chronic inflammation of patients with chronic rhinosinusitis with nasal polyposis
(CRSwNP), severe asthma, and aspirin-exacerbated respiratory disease (AERD). Further, given that some
drugs now available to inhibit these pathways have poorly understood side effects like new-onset joint pain,
we will establish the systemic immunologic consequences of inhibiting a receptor as widely expressed as
IL-4Rα and will identify novel biomarkers to predict those immune responses. In three separate but
interrelated projects, we aim to:
1. Define the cellular mechanism(s) of anti-IL-4Rα-induced therapeutic benefit in AERD with a
prospective study of 8 weeks of dupilumab treatment.
2. Define the systemic immunologic consequences of IL-4Rα inhibition with dupilumab and determine
which immunologic changes correlate with the development of arthralgias.
3. Characterize the functional significance of IL-5Rα on upper airway nasal plasma cells and epithelial
cells, from patients with healthy sinus mucosa, CRSwNP, and AERD.
These goals will be achieved using patient-oriented research (POR), as each of these aims involve patient
interactions and longitudinal study visits to collect and verify clinical outcomes, and through the mentorship
of the next generation of patient-oriented allergic disease investigators. The proposed studies and the
clinical questions to be examined offer outstanding training opportunities for junior investigators interested in
clinically relevant research in allergy and asthma. Dr. Tanya Laidlaw is a recognized investigator in the
causes of CRSwNP and AERD and the candidate's many ongoing POR projects and collaborations,
commitment to and track record of mentorship, along with the exceptional institutional resources, provide a
first-rate environment for the development of junior investigators. Critically, this award will provide Dr.
Laidlaw protected time for POR in airway inflammation and allergic respiratory disease to both refine her
mentoring and leadership skills and expand her expertise to include predictive biomarker identification,
pathway-level multi-omics analysis, and high dimensional data analyses.

Public health relevance
Project Narrative – Public Health Relevance Statement Dr. Tanya Laidlaw is a recognized patient-oriented investigator in the study of respiratory diseases, in particular severe asthma and chronic sinus disease, which collectively afflict up to 10% of the US population and have high morbidity and few available treatments. This project aims to determine which immune pathways are important causes of these inflammatory respiratory diseases, and how new biologic drugs that treat them can work to improve patients’ respiratory health but may also cause other systemic immune consequences. Dr. Laidlaw is a very engaged research mentor, and this grant will support her ability to mentor and train the next generation of clinical scientists in patient-oriented allergic and airway disease research.